Oral Dissolvable Strips (ODS) as new pediatric and adult delivery mode of therapy for latent tuberculosis

PROJECT SUMMARY
Tuberculosis (TB) remains one of the major sources of mortality from infectious diseases worldwide. In 2021 an
estimated 6.4 million were newly diagnosed with TB globally, approximately 10.6 million fell ill from it, and 1.4
million died from the disease. Of those who died from the disease, 54% were men, 32% women, and 14% were
children aged <15 years. TB is also a leading cause of death for people infected with HIV, with 187,000 deaths
due to tuberculosis among HIV-positive people in 2021 (WHO, 2022). People living with HIV are on average 19
times more likely to develop active TB disease than people without HIV, and approximately 1 in 3 HIV deaths
are due to TB. Furthermore, there is a recent increase in TB cases attributable to resources being diverted for
COVID 19. One model, developed by researchers at the London School of Hygiene and Tropical Medicine,
projects that there will be around 200,000 additional deaths from TB across China, India, and South Africa
between 2020 and 2024. While TB is a treatable and curable disease, the treatment of patients with antimicrobial
drugs remains challenging. The extraordinarily long duration of the regimen (min. 6 months), combined with the
phenomenon of dysphagia – especially in pediatric and geriatric patients – is one of the root causes for the lack
of patient adherence. As a result, there is further spreading of the disease and an even more serious problem,
drug resistance. Globally, an estimated 484,000 people developed rifampin resistant or multidrug-resistant TB
(RR/MDR-TB) in 2018. Costs for treating the most drug resistant form of TB are around $513,000, significantly
higher than the average cost of $18,000 for treating nonresistant TB.
Oak Therapeutics is developing a technology that allows life-saving TB drugs to be delivered via Oral Dispersing
Strips (ODS). The ODS approach solves many of the problems associated with current delivery by tablets,
capsules, or liquids, especially when used by infants and small children. In this proposal, Oak Therapeutics’
proprietary technology will be used to create two distinct fixed doses (1 pediatric and 1 adult) of Isoniazid-
Rifapentine (INH-RPT) multi-drug ODS, with the goal of simplifying therapy administration, improving
patient/caregiver privacy and ultimately successfully treating latent TB. In Aim 1 Oak Therapeutics plans to
develop Rifapentine RPT-ODS. Despite being efficacious, RPT is not stable in the presence of long-term
exposure to moisture, heat or direct light. As such, RPT and INH will be encapsulated to minimize the negative
effects of these environmental conditions on the stability of RPT-ODS as well as to make it palatable. In Aim 2,
using experimental design strategy, Oak Therapeutics will determine appropriate conditions for multidrug
formulation and the resulting INH-RPT ODS will be tested against bioequivalent tablets formulation in an in vivo
pharmacokinetic study to be performed in Aim 3. The successful completion of Phase I will lay the foundation of
a Phase II that will focus on the packaging design for the ODS, strategy for provider and caregiver training and
instructional materials and measures for pediatric adherence. Then, a submission packet (505 (b)(2)) will be
prepared for WHO and US FDA review and approval.

Public health relevance
PROJECT NARRATIVE Globally, an estimated of 2 billion people including 45 million children (0 through 9 years) and 217 million adolescents and young adults (AYA; 10 through 24 years) carry latent TB. Current formulations for treatment of pediatric TB, adolescents and adults with comorbidities (e.g. HIV, dysphagia) pose significant caregiver and patient-related barriers to treatment adherence, especially in low income settings. With this application, Oak Therapeutics aims to develop oral dispersing strips (ODS) containing the WHO recommended fixed dose of Isoniazid-Rifapentine TB therapy, designed specifically for improving treatment adherence throughout the affected population.